CEACAM5-targeted activation of potent chemotherapeutics via bioorthogonal click chemistry

Abstract
Shasqi, Inc. is utilizing its innovative Click Activated Protodrugs Against Cancer (CAPAC®) platform to improve
the therapeutic efficacy of cancer treatments by facilitating precise and localized activation of potent cytotoxic
drugs. Many standard-of-care therapies lack tumor specificity and often require high doses to achieve a
therapeutic benefit, which result in significant toxicity and adverse drug events (ADEs). Similarly, antibody-drug
conjugates (ADCs), while designed as targeted therapeutics, deliver less than 2% of the active drug to the tumor
site. A much larger fraction of the dose is distributed to and degraded in healthy tissues, resulting in off-target
toxicities, limiting the therapeutic index. Shasqi’s CAPAC platform overcomes these challenges by using
bioorthogonal click chemistry to activate drugs precisely at the tumor site. The platform is made up of a two-
component system: a tetrazine-modified antigen-targeting conjugate and a trans-cyclooctene-modified prodrug
(a.k.a. protodrug). The first component, the tetrazine conjugate, is designed to bind specifically to tumor-
associated antigens, such as CEACAM5, and is otherwise inert until paired with the second component. The
second component, the protodrug, is inactive until it encounters the tetrazine conjugate at the tumor site. Upon
meeting, a highly specific and rapid chemical reaction occurs between the two components, releasing the active
drug only in the localized area of the tumor, maximizing efficacy and reducing systemic toxicity. This Direct-to-
Phase II project targets CEACAM5, which is an antigen whose expression has been well established in several
cancers with significant unmet need. CEACAM5 has been found in over 90% of colorectal, gastric and pancreatic
cancer cases, and in 25% of non-small-cell lung cancers (NSCLC) cases. CEACAM5 is ideal for localized drug
activation, not just because of its slow internalization kinetics, but also due to its high tumor specificity and
minimal expression in normal tissues. By optimizing CEACAM5-targeted activating agents and conducting
preclinical studies focused on pharmacokinetics, efficacy and tolerability, this project aims to develop a novel
platform for targeted drug delivery. The specific aims of this projects are: 1) Develop and characterize
CEACAM5-targeted activating agent conjugates, 2) Evaluate pharmacokinetic/pharmacodynamic
(PK/PD) properties of preferred conjugates, 3) Demonstrate antitumor efficacy of CEACAM5-binders with
MMAE protodrug in multiple murine tumor models of lung carcinoma and 4) Perform a non-GLP
toxicology study in naïve rats. Aside from cancer therapy, the CAPAC platform also has the potential for
adoption by other therapeutic areas, such as infectious diseases and autoimmune disorders, since it offers
improved therapeutic outcomes with minimal toxicity.

Public health relevance
Narrative Shasqi’s CAPAC platform offers a transformative approach to cancer treatment with minimal toxicity, by facilitating localized drug activation at tumor sites. This technology significantly improves the precision and safety of cancer therapies, by addressing the need for effective treatments with reduced adverse effects. Successful optimization and deployment of the platform could improve survival rates and quality of life for cancer patients while reducing the economic burden of adverse drug events.